Functional outcomes of inflammatory bowel disease associated variants

Project Summary/Abstract
The interplay between microbial and genetic susceptibility factors is central to the development of
inflammatory bowel disease (IBD). Innate mechanisms, in particular through pattern recognition receptor
(PRR) pathways, are the initiating drivers of host responses to microbes. Of the >240 loci associated to
IBD, a number of genes modulate host PRR responses at many levels and confer some of the largest
genetic effects observed in autoimmunity. Despite the significant recent discoveries in IBD-associated
genetics, the functional consequences of the majority of the genetic loci have yet to be identified. A central
outcome of PRR activation by microbial products is induction of cytokine and microbial clearance
pathways. Further, IBD is largely characterized by dysregulated cytokines and anti-microbial responses,
and the inter-individual variation in PRR-induced outcomes influences the disease susceptibility. We
hypothesize that polymorphisms in multiple IBD-associated genes contribute to inter-individual variation
in PRR-induced cytokine and microbial clearance pathways, and that we will be able to more clearly
classify individuals in the context of this dichotomy. Systematic, well-powered studies comprehensively
defining the functional alterations driven by disease-associated human variation can provide enormous
insight into central mechanisms of IBD; leveraging naturally occurring human genetic variation to
systematically “perturb” an experimental system represents an advantageous approach for precisely
defining established and novel PRR-mediated mechanisms mediating the balance between cytokine
secretion and microbial clearance. Therefore, we will utilize a large, well-powered cohort to screen for
IBD-associated polymorphisms contributing to the variation in PRR-initiated cytokine secretion and
microbial clearance across individuals and then define the molecular mechanisms wherein the implicated
IBD-associated genes, as well as the identified polymorphisms, regulate PRR-induced outcomes.
Relevance
These combined studies will provide insight into whether those IBD-associated loci that regulate PRR-
induced cytokine secretion and bacterial clearance do so through a loss- or gain-of-function, the
mechanisms wherein the implicated genes mediate their contributions to these PRR-induced outcomes,
and the specific consequences of the polymorphisms on gene function through examination of monocyte-
derived cells from selected carriers. These comprehensive and mechanistic studies will be crucial for
future studies that will examine gene consequences in vivo and ultimately, for improved disease
classification and therapeutic targeting.

Public health relevance
Project Narrative We have developed a large functional screen to dissect the contributions of inflammatory bowel disease (IBD)- associated polymorphisms to the variation between individuals in pattern recognition receptor (PRR)-induced cytokines; this provides a uniquely powerful means of determining the functional consequences of a number of IBD-associated genetic loci. We will utilize this screen, along with implementing a screen that now evaluates the balance between critical cytokine and antimicrobial pathways, to identify those IBD-associated polymorphisms contributing to PRR-initiated outcomes and then dissect the mechanisms wherein both the genes and the specific polymorphisms within the genes modulate these outcomes. We anticipate that studies focused on disease-associated polymorphisms that modulate the balance between cytokines and antimicrobial pathways, the dysregulation of which is a major feature of IBD pathogenesis, will ultimately result in improved disease classification and in prioritization of new therapeutic targets for IBD.